ACTG 343--PROTECTIVE RANSOMIZED DOUBLE BLIND THREE MAINTENANCE REGIMENS

Compare the sustained suppression of plasma HIV RNA among three treatment regimens containing combination of ZDV, 3TC, and IDV after 24 weeks induction therapy with ZDV/3TC/IDV.